Circuit mechanisms of self-organized cognitive strategies

Project Summary
Decades of psychology research have shown that working memory is limited, and humans can only hold a few
items in mind at the same time. However, cognitive tasks like planning and problem solving require access to
many pieces of information at once. To overcome this constraint, we enlist mnemonic strategies, for instance
grouping pieces of information into chunks, as we commonly do to remember telephone or social security
numbers. Mnemonic chunking allows us to flexibly organize information on line, providing a fundamental
building block for advanced cognitive abilities. Chunking impairments occur when damage or dysfunction
involves the dorsolateral prefrontal cortex (dlPFC), for instance in patients with schizophrenia, and severely
compromises overall cognitive function. Thus, determining how the brain organizes information is a necessary
step toward understanding the mechanisms of advanced cognition, and how these go awry in disease states.
A key challenge is that strategies for organizing information are self-generated and highly variable in a
laboratory setting. A central innovation of this proposal is the novel computational approach used to identify
spontaneous mnemonic chunking in macaque monkeys. This is critical because animal models allow us to
interrogate brain function with advanced neurophysiological tools. Here, we will use high-density, multi-site
recording and targeted neuromodulation to understand the circuit mechanisms that chunk mnemonic
information. Previous theoretical work suggests that chunks arise from compressed working memory
representations that act as neural shorthand, economizing on processing resources at the cost of degrading
some original information. Neurons in dlPFC encode items in working memory, and their dynamics are shaped
by recurrent interactions with the basal ganglia. Thus, we hypothesize that corticostriatal interactions promote
the efficient reorganization of working memory that underlies chunking. To test this we will investigate dlPFC-
striatal dynamics when monkeys spontaneously chunk information in a self-organized working memory task.
We will record large numbers of single neurons and local field potentials, and dynamically decode
representations held in working memory to assess how mnemonic codes and corticostriatal interactions
change when items are or are not chunked. In addition, exogenous stimulation will test the causal role of
striatal circuits in promoting the formation of mnemonic chunks. Together, these experiments will determine
how the brain establishes mnemonic chunks to optimize working memory performance. This will shed light on
a fundamental feature of advanced cognition, and how dysfunction in these mechanisms could give rise to
disorders of thought and memory. Finally, understanding mechanisms that optimize cognitive function in a
biological system may fuel creative advances that optimize performance in artificial intelligence systems.

Public health relevance
Project Narrative This project focuses on understanding circuit dynamics in the prefrontal cortex that mediate mnemonic chunking, a critical strategy for improving working memory performance in advanced cognition. Specifically, we will assess how mnemonic information is bound together in the dynamics of frontal and striatal circuits, and whether these processes can be enhanced with targeted circuit modulation. Our results could provide insights into core deficits in cognitive disorders, such as schizophrenia, and open the door for novel approaches that enhance cognitive function in the setting of working memory deficits.